Dissecting the DNA Damage Response with Functional Proteomics

SUMMARY
The DNA damage response (DDR) entails a tightly choreographed reorganization of protein complexes involved
in DNA repair and damage checkpoints. Post-translational modifications (PTMs) fulfil a crucial role in the DDR.
However, the mechanisms by which these changes in proteome are dynamically controlled remain elusive.
Particularly, much remains to be learned regarding which kinases other than well-characterized ones (e.g., ATM,
ATR, DNA-PKcs) are involved in the process, how protein phosphorylation is erased by phosphatases, and how
DDR proteins temporally regulate the recruitment and activity of kinases and phosphatases are not clearly
understood. We have developed state-of-the-art mass spectrometry (MS)-based functional proteomics tools to
globally monitor and quantify changes in protein abundance, protein-protein interactions (PPIs), and PTMs within
the context of DDR, facilitating identification of novel regulators and mediators of DDR and providing mechanistic
insights into their functions.
With quantitative proteomics and systems biology tools combined with biochemical and cell biological
approaches established in my laboratory, this MIRA R35 research program aims to define the functional
interactome of DDR proteins and mechanistically delineate PTM circuitries to better understand DNA repair
mechanisms. Specifically, we will investigate the mechanism by which the ARAF kinase regulates DDR through
interaction with RAD51D and examine DNA repair defects associated with ARAF depletion and/or kinase activity
inhibition to define a novel DDR-regulatory kinase pathway. Moreover, based on our own published results (Kim
et al, Science, 2021, PMID:34591612) implicating Spinophilin (SPN), a substrate targeting subunit of protein
phosphatase PP1, in the DRR via its association with the tumor suppressor BRCA1-BARD1, we will analyze the
spectrum and kinetics of SPN-PP1-mediated protein dephosphorylation within DDR by analyzing the phospho-
proteomes of SPN wild-type and mutants cells. Lastly, based on our preliminary interactome data that SPN
interacts with RSBN1L (histone H4K20me2 demethylase), we will investigate whether BRCA1 recruits RSBN1L
through its interaction with SPN to DNA double strand break sites to demethylate H4K20me2, which we surmise
to create a chromatin environment conducive for BRCA1-BARD1 recruitment. We will also analyze whether
RSBN1L regulates the choice of DSB repair pathways between HR and NHEJ by regulating the chromatin
association of BARD1 and 53BP1.
Our research program will capture dynamic PPIs and PTMs that help ensure the timely execution of DDR and
dissect novel DDR regulatory mechanisms.

Public health relevance
NARRATIVE Proteins involved in the DNA damage response fulfil a crucial, multi-faceted role in repairing DNA damage and maintaining genome integrity, in concert with many other proteins involved at multiple distinct steps. The association between DDR proteins is precisely and temporally controlled often by post-translational modifications. Using mass spectrometry-based functional proteomics tools combined with biochemical and cell biological approaches, our research program will define the functional interactome of DNA damage response proteins and interrogate post-translational modification circuitries to identify novel regulators and mediators of DNA damage response and understand their mechanisms of action during DNA repair.